PH I &II MC,R,DB,VC, STUDY OF S&TE OF TOPICAL R 848 GEL IN UVRI HERP

The primary objective of this study is to evaluate the safety profile of multiple doses of R-848 applied topically to orolabial skin after exposure to UVR to induce ractivation of herpes lbialis.